Development of Fluorescent False Neurotransmitters

SUMMARY
Development of Fluorescent False Neurotransmitters
Monoamine neurotransmission plays important roles in modulation of excitatory and inhibitory synapses in the
central nervous system and thus provides essential fine tuning of behavior in response to a changing
environment. Consequently, aberrations in monoamine neurotransmission underlie many neurological and
neuropsychiatric disorders including Parkinson’s disease, schizophrenia, ADHD, depression, and drug
addiction. We have established an interdisciplinary research program focused on development of new
molecular probes to study monoamine neurotransmission on a synaptic level. Specifically, we have introduced
a conceptually new class of probes, termed “fluorescent false neurotransmitters” (FFNs), that act as optical
tracers of dopamine and norepinephrine. FFNs provide the first experimental means to image synaptic vesicle
content uptake and release at individual presynaptic varicosities in brain tissue and in living animals. Using
FFNs and multiphoton microscopy imaging we have made several unexpected findings, including the discovery
of silent dopaminergic and noradrenergic synapses, activity-dependent super-charging of synaptic vesicles,
and mechanistic insights on psychostimulant drugs. In this renewal application, we propose to expand the
scope of FFNs to serotonin synapses, the third major monoamine system, on the basis of proof-of-concept
studies. We will also develop new imaging and photon-counting methods based on the combinatorial use of
FFNs as presynaptic probes with emerging genetically encoded monoamine reporters as postsynaptic sensors
to provide multi-parameter synaptic readouts in living mice. In addition to complementing each FFN class with
the corresponding sensor (for example, dopamine FFN and dopamine sensor), mixing and matching FFNs and
sensors each for a different monoamine will enable simultaneous examination of two neurotransmitter
systems. This in turn will enable the study of complex processes such as co-transmission and neurotransmitter
switching on a synaptic level. We will also examine the effect of monoamine releasing agents on synaptic
neurotransmitter dynamics at the dopamine, norepinephrine, and serotonin axonal release sites to probe both
the vesicular pools in active and silent varicosities and the mechanisms of action of these psychoactive drugs.
This application addresses a major unmet need in developing molecular tools and methods for imaging
multiple neurotransmitter systems in living animals with adequate spatial and temporal resolution.

Public health relevance
Project Narrative Monoamine neurotransmitters such as dopamine, norepinephrine, and serotonin play essential roles in the nervous system by fine tuning learning and behavior, and malfunction of monoamine neurotransmission has been implicated in numerous neuropsychiatric diseases (depression, anxiety, substance use, and Parkinson’s disease). We will develop new imaging probes and methods to enable detailed readouts of neurotransmission processes on a synaptic level and advance neurobiology and neuropharmacology.